Biostatistics and Data Management Section

The Section is the statistical and data management component of the Center for Cancer Research (CCR). The Section provides statistical leadership and data management consultation for major activities of the Center, and is involved in the design, conduct, monitoring, and statistical analyses of intramural and national multi-center clinical trials of experimental treatments for cancer, and intramural clinical trials for treatment of AIDS. The section provides a broad range of data analysis and consultation services to laboratories performing basic scientific research into the origin and growth mechanisms of cancer and AIDS. Other major collaborative efforts include studies to identify important prognostic and treatment selection factors, evaluate diagnostic procedures, develop improved staging systems, and assist investigators in the design, execution, and analyses of major in vitro drug testing studies. The Section develops and implements new statistical designs and biometric methods related to the development and evaluation of new cancer and AIDS treatments. Approximately 20 percent of the Section's activities are HIV/AIDS related.